Characterizing the Natural History of Fragile X Syndrome to Inform the Development of Intervention,Outcome Measures

SUM M ARY
The purpose of this proposal is to build on the foundation of the Fragile X Online Registry With
Accessible Research Database (FORWARD) and obtain more detailed longitudinal data
describing the phenotype of children and young adults with fragile X syndrome (FXS) in order to
better characterize the natural history of fragile X syndrome (FXS). A product of the study will be
to understand the longitudinal trajectory of meaningful outcomes that impact the lives of children
and adolescents with FXS with and without autism spectrum disorder (ASD), and from different
racial/ethnic groups and geographic locations across the United States. The research will
characterize cognitive, behavioral, and adaptive skills, and other indicators of functioning of
individuals with FXS, and determine how these outcomes relate to diagnostic history, early
intervention, and access to services. Finally, this study will collect data to explore the practical,
financial, and psychological impact that caring for a family member with FXS has on caregivers
and siblings of those with FXS. Post-award, outcomes to be measured will be chosen in
coordination with CDC's Study to Explore Early Development (SEED) Follow-up Study (RFA-
DD-21-001) and will include standardized in-person behavioral and functional assessments and
follow-up computer-assisted telephone survey questionnaires. Data from this project and the
SEED project will be collected and housed in a secure electronic data system maintained at a
CDC-contracted organization. Outcomes chosen for study will facilitate comparison of health
and functional outcomes for the FXS population with those for other related and frequently co -
occurring conditions, such as ASD and developmental delay. Outcome data will assist with
identifying public health gaps affecting those with FXS, inform service delivery
recommendations and inform design of interventional studies, all with the goal of improving the
lives of those with FXS and their families.

Public health relevance
NARRATIVE The overall objective of the project described in this application will be to collect natural history data at 26 FXS Clinics in the USA, from 600 individuals with FXS born between 2003-2017, including longitudinal data from half the cohort. Data will be used for analyses that will lead to a better understanding of the impact of earlier diagnosis, services received, and medical/social issues, on later cognitive, behavioral, and adaptive function. This will inform public health policy, service delivery recommendations, and will provide longitudinal data to inform outcomes for long-term intervention trials in FXS, thus fostering better health, functioning, and quality of life among persons with FXS and their families.